A community-based adaptation of a peer-led intervention to address alcohol use and HIV risk in pregnant women in South Africa (Mentor Moms+)

PROJECT SUMMARY
The syndemic of alcohol use and HIV risk in pregnant and lactating people (PLP) threatens the health of
mother, fetus, children and families in South Africa. PLP living with HIV who use alcohol may access
antiretroviral therapy (ART) late or disengage with ART care, increasing the risk of vertical HIV transmission.
PLP not living with HIV who use alcohol are at increased risk of HIV and may require targeted interventions to
receive pre-exposure prophylaxis (PrEP) delivery and adherence counselling. Alcohol use also increases risk
of HIV acquisition and poor ART adherence. The “mentor mother” (MM) intervention model is an evidence-
based intervention (EBI) with demonstrated success in improving HIV and antenatal care outcomes. The
model utilizes a task-shifting approach; positive deviant peers (mothers) deliver interventions to PBFW within
and outside of the antenatal clinic. In the present study, we will collaborate with community partners to identify
facilitators of alcohol use among PLP in SA. We will then adapt the MM model to create MM+ for PLP who
use alcohol to evaluate the feasibility of an alcohol reduction intervention that includes HIV prevention and
treatment (serostatus neutral) in a high alcohol using and HIV burdened community. Specific aims include:
· Aim 1: Mixed methods assessment of perceptions of alcohol use in pregnancy and facilitators of
alcohol reduction in pregnancy among multilevel stakeholders of PLP who use alcohol to identify
clinic and community level facilitators that could be used to reduce the use of alcohol during
pregnancy through in-depth interviews (IDIs) and brief surveys with drinking peers, intimate partners and
focus group discussions with healthcare providers and community leaders.
· Aim 2: Adapt and refine enhanced MM intervention (MM+) with potential intervention beneficiaries,
providers and community leaders. Use community based participatory approach research principles to
iteratively adapt, test and refine the MM+ intervention to integrate alcohol reduction content in one
collaborative workshop session.
· Aim 3: Evaluate the feasibility and acceptability of MM+ on reduction of alcohol use (primary
outcome) and PrEP use (in PLP without HIV) and ART adherence (in PLP living with HIV)
(secondary outcomes) in a pilot randomized control trial (RCT) in n=100 pregnant women who currently
use alcohol. Primary outcome: Reduced alcohol use following the intervention (at 6m via
phosphatidylethanol [PEth] levels). Secondary outcomes: PrEP and ART continued use at 6m via urine
tenofovir levels at 6m. Secondary implementation outcomes: feasibility (provider, organizational and
participant feedback), acceptability and fidelity to the intervention SOPs.
Our study seeks to effectively reduce alcohol use and improve HIV care outcomes through community
engagement and a novel participant informed intervention adaptation and delivery process.

Public health relevance
PROJECT NARRATIVE South Africa has the highest combined prevalence of alcohol use in pregnancy and HIV in the world; pregnant women without HIV require access to effective HIV prevention including oral pre-exposure prophylaxis (PrEP), and pregnant women living with HIV who use alcohol may access antiretroviral therapy (ART) late or disengage with ART prior to or during pregnancy, increasing the risk of vertical HIV transmission. There are no evidence-based, community-informed interventions available to minimize the range of negative health outcomes due to alcohol and HIV in pregnancy. Our innovative study seeks to: · Aim 1: Conduct a mixed methods assessment of alcohol use in pregnancy and facilitators of alcohol reduction in pregnancy among multilevel stakeholders of pregnant women who use alcohol to identify clinic and community level facilitators that could be used to reduce the use of alcohol during pregnancy; · Aim 2: Adapt and refine an evidence-based HIV prevention intervention, Mentor Mothers (MM+), to include perinatal alcohol use and HIV care with potential beneficiaries (pregnant women who use alcohol), healthcare providers and community leaders; · Aim 3: Evaluate the feasibility and acceptability of MM+ on reduction of alcohol use (primary outcome) and PrEP use (in pregnant women without HIV) and ART adherence (in pregnant women living with HIV) (secondary outcomes), as well as feasiblity (among providers), acceptabilty (among pregnant women) and fidelity to the intervention, to inform future research and scaled interventions in South Africa and throughout the region.